Breaking Barriers: Innovating HIV Elimination with Social Network Strategies and Routine Substance Use Screening

ABSTRACT
This proposal focuses on identifying viremic and/or people with substance use disorder (SUD), to engage for
early intervention, as these often-overlapping populations are key drivers of the remaining HIV epidemic in the
U.S. An estimated 80% of new HIV transmissions result from persons with diagnosed infection who are not
receiving regular care (43%) or do not know they have HIV infection (37%).1 HIV incidence in the U.S. remains
the highest among sexual and gender minorities of color (SGMC).2 Substance use is common among SGM,3,4
and impacts HIV transmission. Viral suppression is 20% lower among people with SUD,25 yet screening for SUD
is not integrated in most federally qualified health centers (FQHC)s.26,27 In Chicago, viral suppression among
SGMC is ~60%.28 Interventions to identify and treat SUD among SGMC can significantly reduce population level
HIV incidence,29 but strategies to ensure universal identification of SUD must be improved.
Proposed Solution. We propose a two-prong Hybrid Type I trial34 at a large FQHC network that primarily serves
SGM in Chicago, IL. The first-prong is implementing routine screening for SUD (using the NIDA Quick Screen
1.038); and the second is a social network intervention (SNI) to identify individuals who are viremic, have SUD,
or both and link them to harm reduction and HIV continuum of care services.
Although social network methods have been successful at finding people unaware of their serostatus, and have
demonstrated effectiveness in finding viremic SGMC through simulation studies,36 they have not been adapted
as an intervention for finding PLWH who are viremic or people with SUD to support HIV elimination.35,37 The
present study will test the system-wide implementation of a SUD screener and SNI for finding SGMC who are
viremic and/or have SUD. To study implementation, we will conduct a rigorous mixed-methods evaluation across
all study years guided by EPIS (Exploration, Preparation, Implementation, Sustainment)38 as the determinants
framework and the Proctor Implementation Outcomes Framework (IOF)39 as the evaluation framework. The
specific aims are:
Aim 1: Evaluate the effectiveness of the SUD Screening and SNI implemented at a large FQHC. Aim 1a:
Estimate the increased rate of SUD detection with the SUD screener vs. EMR documentation. Aim 1b: Evaluate
whether the SNI is effective at identifying people who are viremic and/or have SUD compared a functional
control (new or re-engaged FQHC patients seen during the same period). Aim 2: Develop a multifaceted
implementation strategy package to support the adoption and sustainment of SUD screening + SNI in
organizations serving SGMC. Aim 3: Evaluate the potential population-level reduction in (i) new HIV infections,
(ii) individuals out-of-care, and (iii) individuals virally unsuppressed over 10-years if SU screening and SNI are
implemented across Chicago.

Public health relevance
NARRATIVE This study proposes a two-prong Hybrid Type I trial34 at a large federally qualified health center (FQHC) network that primarily serves sexual gender minorities of color (SGMC) (who experience the highest HIV incidence) in Chicago, IL to curtail HIV viremia and substance use disorder (SUD). The first prong is implementing routine SUD screening at the FQHC; and the second is a social network intervention (SNI). Together these efforts will identify individuals who are viremic, have SUD, or both and link them to services, and develop a multifaceted implementation strategy package to support the adoption and sustainment of SUD screening + SNI in other organizations serving SGMC.